RESEARCH TRAINING AND EDUCATION

The number, characteristics, and skills of individuals in the health professions have profound implications for efforts to reduce health disparities. It is particularly important to increase the number of health professionals, who are themselves from minority groups. It is also important for all health professionals, both from minority and non-minority groups, to learn how to address health disparities through patient care, research, and/or teaching. We propose to develop a comprehensive, coordinated, and collaborative program of recruitment, education, and retention designed to expand the workforce of health providers, researchers, and faculty working to reduce health disparities. Our specific aims are: A) To effectively recruit and retain students, particularly those from minority backgrounds, into undergraduate, graduate, and postdoctoral educational programs related to health disparities; B) To provide diverse educational opportunities for undergraduate and graduate students emphasizing knowledge and skills in research to reduce health disparities; C) To identify, recruit, and support post-doctoral fellows and junior faculty, particularly those from underrepresented groups, to ensure their successful entry into academic positions focused on biomedical and behavioral/social research to reduce health disparities; and D) To develop and institutionalize support structures to ensure the sustainability of this initiative. Formative and summative evaluation strategies will be used to ensure successful accomplishment of these aims. This project brings together and builds on resources and prior successes of the largest health professional educational institutions and world-class health care institutions in the region. The newly coordinated resources created through this Research Education and Training Core will help develop the next generation of health providers, researchers, and faculty who will lead efforts to improve the health of minority and underserved individuals and communities.